2024 Kern Lipid Conference: "Lipids and Mitochondria in Cardiometabolic Diseases"

SUMMARY
Since its inception in 1985, the goals of the Kern Lipid Conference have been to promote metabolic science and
increase understanding of metabolic pathobiology and cardiovascular disease. The conference strives to provide
an inclusive, open forum for established and young emerging scientists from academia and industry. The 2024
Kern Lipid Conference will be co-chaired by Drs. Jonathan R. Brestoff, Nada A. Abumrad, and Gregory Steinberg
and will have the theme “Lipids and Mitochondria in Cardiometabolic Diseases.” It will be held August 12-
14, 2024 at the Viceroy Hotel in Snowmass, Colorado. The primary goals of the 2024 conference are (1) to
provide a dynamic interactive environment that leads to novel insights into disease mechanisms involving lipid
metabolism and mitochondrial function and (2) to engage and inspire young scientists from diverse backgrounds
to develop their careers studying lipid biology, mitochondria metabolism, and cardiometabolic disease
pathogenesis. We will examine multiple organ systems including the cardiovascular system, heart, liver, brain,
and adipose tissue while delving into metabolic diseases including obesity, diabetes, nonalcoholic fatty liver
disease, and atherosclerosis, and other associated conditions such as cancer and neurodegeneration. The
program will feature 5 sessions on exciting new areas of research: (1) Lipids and Mitochondrial Metabolism in
the Brain, (2) Immune cells and Lipids in Cardiometabolic Diseases, (3) Mitochondria Transfer in
Cardiometabolic Diseases, (4) Lipids and Mitochondrial Metabolism in the Regulation of Cardiometabolic
Disease Pathogenesis, and (5) Lipids in Cancer. There will be 33 talks over a 3-day period (10 from early career
scientists), an evening poster session, and career development sessions for early career scientists. Breaks,
lunches, a closing dinner, and a closing reception on the premises promote interactions between participants.
Idea exchange is maximized by allocating ample time for questions and discussion after oral presentations. The
Kern Conference has traditionally attracted many early career scientists (~40% of the participants) and
established scholars in their fields as well as creative scientists from industry. Participation of young scientists is
strongly promoted with oral presentation opportunities, the poster session, inviting them to serve as session
chairs, and awarding 3 prestigious early-career awards that will advance their career development: the Roger
Davis Investigator Award for Transitional Faculty, the David L Williams Lecture and Scholarship Award, and the
Franz Simon Poster Award. The setting and meeting format will facilitate interaction and discussion among
attendees, making it likely that novel insights into disease mechanisms and therapeutic approaches for
cardiometabolic diseases and associated comorbidities will emerge from the 2024 Conference. This R13
application is critical to the success of the 2024 Kern Conference because it will enable us to support the
attendance and highlight the research from more early career scientists (graduate students to Assistant
Professor), especially those who are from underrepresented groups in biomedical research.

Public health relevance
NARRATIVE The Kern Lipid Conference has traditionally promoted metabolic science and increased understanding mechanisms of metabolic disease pathogenesis, and it will be focused on a new theme of “Lipids and Mitochondria in Metabolic Diseases” in 2024. The overall goal of this conference is to explore the major mechanisms by which lipids and mitochondria function in a variety of tissues in obesity, type 2 diabetes, heart failure, myocardial infarction, atherosclerosis, neurodegenerative diseases, cancer, and other diseases based on recent scientific breakthroughs. The 2024 Kern Conference program bring together internationally recognized scientists and early career scientists (graduate students to Assistant Professors) to provide a forum that fosters interaction with basic and translational scientists in academia and industry, enables attendees to spark creative new ideas that cut across fields, breaks down barriers between investigators in these areas of research, and supports the career development of emerging early career investigators.